Dr. Salma Jabbour’s NCI Research Specialist (Clinician Scientist) Award (R50)

ABSTRACT
Oncology clinical trials are increasingly complex in their design, management, and oversight, and clinical trials
continue as the cornerstone to transform cancer care for patients. These multifaceted trials require significant
partnership from the institution and investigators to provide support and effort as well as multifaceted teams to
conduct and execute these trials seamlessly and effectively. Furthermore, the dissemination of clinical trial
findings in a timely and efficient manner requires the continued support from the clinical trials teams,
biostatisticians, and co-investigators in terms of time and effort. Dr. Jabbour is a seasoned research specialist,
physician scientist, and clinician scientist having a proven track record of diligence and innovation as well as
purpose to design, carry out, and complete clinical trials. Her long-standing commitment to clinical trials is
paramount as she is a leader at the Rutgers Cancer Institute of New Jersey in mentoring and supporting other
clinical trialists, having overseen the Human Research Oversight Committee (HROC/DSMB) and currently
overseeing the Scientific Review Board, and she plays integral role in the oversight of clinical trials through a
variety of committees both at Rutgers Cancer Institute and nationally. At the national level, Dr. Jabbour is the
contact PI for the Rutgers Cancer Institute ETCTN/CTEP grant funding, is a long-standing Co-Chair for the NCI
Radiation Research Program Gastrointestinal Interest Group, and is actively involved in a variety of NCI
Cooperative Group Committees and Protocols including the ECOG-ACRIN and NRG Oncology Cooperative
Groups. Dr. Jabbour is a continued leader and pioneer as a clinician scientist and actively studies the use of
novel agents in combination with radiation in ground-breaking clinical trials. Dr. Jabbour will continue her
exemplary efforts and work under the auspices of this R50 Mechanism and will continue to revolutionize the
care for oncology patients through her state-of-the-art concepts and collaborations through the NCI national
cooperative groups.

Public health relevance
PROJECT NARRATIVE The NCI Research Specialist R50 Grant will support the development of continued research career opportunities for exceptional clinician scientists, such as Dr. Salma Jabbour, who have demonstrated and plan to continue leadership in the NCI clinical trials networks, development of institutional clinical trials, and national service to NCI clinical trials. Dr. Jabbour is a clinical trial and institutional leader in the oversight and implementation of institutional and national clinical trials whose work has focused on combination therapies with radiation as well as the mentorship and development of early career investigators.